STRUCTURAL PROTEINS IN DISORDERS IN KERATINIZATION

Skin biopsies and keratinocytes cultured from subjects with disorders of keratinization will be studied by morphologic, biochemical and immunochemical techniques to detect abnormalities in epidermal protein expression.